Resurgent Currents in Human Dorsal Root Ganglia

ABSTRACT
Voltage-gated sodium channels (VGSCs) are critical gatekeepers of nociceptor excitability. In nociceptors,
VGSCs are required for nociception, chronic pain, and their increased function causes pain without injury. Most
of our knowledge of VGSCs in nociceptors and their alterations in chronic pain come from rodent and
heterologous expression system studies. However, emergent studies on human dorsal root ganglia reveal
prominent species differences in VGSC expression, kinetics, pharmacology, and modulation. Thus, the premise
of this study is to thoroughly characterize unique sodium currents biophysics in human dorsal root ganglia (DRG)
neurons, which will identify novel therapeutic targets and lead to the development of nonopioid analgesics. Our
recent spatial sequencing studies revealed that β4 is highly expressed in all human dorsal root ganglia neurons
but, in mice, confined to large-diameter neurons and C-low threshold mechanoreceptors, which are generally
non-nociceptive. Half of large-diameter, but not small-diameter (generally nociceptive), murine DRG neurons
exhibited resurgent current. This strongly suggests that human nociceptors generate resurgent currents.
Focusing on interactions between VGSCs and their known modulators, I will determine whether human
nociceptors display resurgent sodium currents, if resurgent currents are potentiated by nociceptor
sensitization, and if they are driven, at least in part, by intracellular interactions between VGSCs and
NAVβ4 and/or FGFs. In nociceptors, resurgent sodium currents may dramatically increase neuronal activity by
augmenting spontaneous activity, evoking persistent current, and mediating repetitive firing. In the context of
pain, resurgent sodium currents may convert mild nociceptor activation to trains of action potentials that can
provoke intense pain and lead to activity-dependent plasticity in central synapses. To address my hypothesis, I
will exclusively use human dorsal root ganglia from organ donors. Aim 1 will use bioinformatics to thoroughly
characterize VGSC and modulator expression in human nociceptors. Aim 2 will employ patch-clamp
electrophysiology to characterize tetrodotoxin (TTX)-resistant and -sensitive resurgent currents in human
nociceptors. Aim 3 will model sensitization dependent voltage-gated sodium channel binding to modulators and
examine sensitization-specific isoforms. This work will elucidate how unique expression patterns of VGSCs and
their modulating proteins contribute to nociceptor sodium current, which is essential for understanding human
nociception. This training opportunity will leverage advanced training in human molecular neuroscience that can
only be done in a few labs in the world, guided by experts in sequencing technologies, electrophysiology and
bioinformatics, and will prepare me for an independent academic career.

Public health relevance
PROJECT NARRATIVE Voltage gated sodium channels (VGSCs) are critical gatekeepers of nociceptor excitability that mediate acute and chronic pain. We discovered that VGSC modulatory proteins that evoke resurgent sodium current are expressed in human, but not murine, nociceptors, strongly suggesting that human nociceptors display resurgent sodium currents. This study will exclusively use human dorsal root ganglia and, focusing on resurgent current in nociceptors, characterize sensitization- and pain-dependent alterations in VGSC expression, modulation, and function.